INVITD II

This is the second wave of data collections for a Phase II clinical trial, the Investigation of Vitamin D and Menstrual Cycles trial (the inVitD Trial). The purpose is to investigate vitamin D’s influence on the hypothalamic-pituitary-ovarian axis by careful evaluation of hormonal and ovulatory changes that occur with vitamin D treatment.